Cell types, circuitry, and development of the visual ventral thalamus

PROJECT SUMMARY
In the visual system, retinal axons convey visual information from the outside world to numerous and distinct
brain regions. In rodents, one major area that is densely innervated by retinal input is the visual thalamus. Mouse
visual thalamus serves as a powerful model system in understanding sensory circuit development, based on its
orderly structure and ease of accessibility for experimental manipulation. Visual thalamus, or lateral geniculate
nucleus (LGN), is divided into three distinct regions: dorsal geniculate nucleus (dLGN), ventral lateral geniculate
nucleus (vLGN), and the intergeniculate leaflet (IGL). Cytoarchitecture and circuitry of dLGN are well-studied,
and it is known to be important for classical image-forming vision. vLGN is associated with non-image-forming
vision and its complete neurochemistry, cytoarchitecture, and retinothalamic connectivity remain unresolved,
raising fundamental questions about its functional role within the visual system. Identifying the structure and
function of neural circuits related to non-image-forming vision is crucial for understanding how light exerts its
influence on programming an individual’s circadian cycle, mood disorders, fear perception, and eye movement
and head movement in response to certain changes in the visual environment. Using state-of-the-art single-cell
sequencing and proteomics, we can identify a comprehensive list of the cells in vLGN. Using in situ hybridization,
immunohistochemistry, and genetic reporter lines, we found that the subtype-specific laminar distribution of
retinorecipient cells in vLGNe is determined during embryonic development. In vLGNe, the retinorecipient portion
of vLGN, studies have demonstrated at least six transcriptionally distinct subtypes of inhibitory neurons that are
distributed into distinct adjacent sublaminae. Using trans-synaptic viral tracing, we can identify the inputs and
outputs of these distinct vLGN cell types with both cell type- and region-specific resolution. By genetically
removing visual input, we found that molecular cues and activity from retinal ganglion cells play important roles
in the development of cells and circuits in vLGN. Using in situ hybridization, immunohistochemistry, and genetic
reporter lines, we can test the role of retinal axons and activity, through retinal and non-retinal morphogens, in
vLGN development. Taken together, the proposed studies will not only identify novel subtypes of vLGN cells,
but also point to new means of organizing visual information into parallel pathways by anatomically creating
distinct sensory channels. This subtype-specific organization may be key to understanding how the vLGN
receives, processes, and transmits light-derived signals in the subcortical visual system. Elucidating these
pathways will give potentially generalizable principles in how sensory information is organized in the brain, and
this would be the first such characterization of non-image-forming visual circuits.

Public health relevance
PROJECT NARRATIVE This project focuses on the development of cells and circuits within the mouse visual system, with the long-term goal of gaining a better understanding of how we might regenerate these circuits in diseases or trauma that result in vision loss. Our lab has shown that disruption of these circuits in the visual system is associated with diseases such as glaucoma, which impacts millions of Americans and results in a significant economic, social, and emotional burden on our society. By studying the underlying mechanism of these diseases, we hope to contribute to the development of therapeutic interventions, ultimately helping relieve some of this enormous burden.